Injectable 3D-Clustered Human Fibroblastic Reticular Cells for Expanding Regulatory T Cells

Allograft transplant rejection is currently managed mainly by pharmacological
immunosuppression. Many organs recipients’ quality-of-life are compromised because of the
non-specific nature of the current therapies. Induction of allograft immunological tolerance has
been the primary goal of new immunotherapies amongst which infusion of regulatory T cells
(Tregs) is a prominent strategy being evaluated in clinical studies. While the outcomes of some
of the human trials are promising, the costly and complex processes of manufacturing several
hundred million Tregs in clinical grade facilities will limit in the near term the number of
transplant recipients who would benefit from the cell-based therapy. In the current project we
seek to advance an alternative method to leverage Treg-mediated tolerance by formulating
fibroblastic reticular cells (FRCs) into injectable 3-dimensional (3D) lymphoid niches. Rodent
studies have shown that FRCs effectively support Tregs in vivo and mediate T cell tolerance.
While lymph node stromal cells can be isolated from patients in routine biopsies, only a few
studies have evaluated the potential of FRCs as therapeutics. Injection of single-cell FRCs
results in their dispersion in the body and destruction of their native physical and biological
attributes. The 3D FRCs formulation we have developed is enabled by a cross-linking porous
biomaterials scaffold. The injectable clustered FRCs (clFRCs) will be studied in two specific
aims. In Aim 1 we will optimize the prototype to generate Tregs in vitro by tuning the cross-
linking density. In Aim 2, the prototype and the top 2 performing optimized clFRCs formulations
will be characterized in humanized mouse models to track the migration of FRCs and the
capacity of the cell depots to support Tregs in vivo. Our MPI team is uniquely qualified to
advance the research given the complementary expertise in biologics delivery and modeling T
cell homeostasis in humanized mouse models. The data generated in this work will pave the
way for translational studies of FRCs as cell therapies aimed at tolerance induction in allograft
transplantations.

Public health relevance
The purpose of the project is to develop lymph node-derived fibroblastic reticular cells (FRCs) into a form of cell therapies to expand and support regulatory T cells (Tregs), a predominant mediator of immunological tolerance in allogeneic transplantations. The objectives are to evaluate and optimize the formulation of 3-dimensional clusters of human FRCs (clFRCs) as injectable lymphoid niches. The experiments will generate results important for developing treatments for reducing the need for non-specific pharmacological immunosuppression in organ transplant recipients.